Layered Cellulosic Scaffolds for 3D Tumor Cell Culture

Nano Terra, Inc. proposes to develop novel 3D cellulosic scaffolds, constructed by stacking 2D layers, which enable the precise establishment of chemical gradients indicative of the in-vivo tumor microenvironment. Each layer is constructed using a simple guiding principle: minimize inhibition of phenotypic development by essentially “staying out of the cells’ way.” The scaffolds will contain extracellular matrix (ECM) mimics consisting of a minimal number of components, which can be stored in a dry state without refrigeration for periods of at least 6 months. In Phase I, in conjunction with the University of Maine and Seahorse Bioscience, we will demonstrate a scaffold that (1) supports the 3D growth of human tumor cells, including co-culture with multiple cell types; (2) replicates the in-vivo tumor microenvironment; (3) recapitulates the correct tumor phenotypes; (4) provides the ability to section 3D tumor constructs by simple destacking of layers; and (5) contains all reagents and chemical factors for tumor growth, without need for refrigeration. The Phase II effort will focus on scaffold validation, incorporating the scaffolds into commercial 24- and 96-well microplate formats, and manufacture of 5000 plates for commercial sale.